Core E: Informatics

INFORMATICS CORE - CORE E: ABSTRACT The Informatics Core (Core E) is responsible for all aspects of data management and data integrity. The specific aims of the Informatics Core are: (1) data management (including database development, data entry and quality control), (2) maintenance of the web-based data system that houses the data, (3) preparation of data files for analysis by BIOCARD investigators, (4) maintenance of the BIOCARD website, (5) facilitating data sharing by outside investigators, (6) preparation of datasets for outside investigators, and facilitating the transfer of MRI scans, biospecimens, and autopsy specimens to outside investigators, consistent with the Data Sharing Agreement of the BIOCARD Study.